Controlling Vaccine Kinetics with Small Molecule Drugs

PROJECT SUMMARY
Infectious diseases such as HIV, malaria, tuberculosis, and seasonal influenza epidemics and emergence of
new pandemics remain major global health problems highlighting the need for innovative approaches in vaccine
design. The precise kinetics of antigen exposure relative to inflammatory cues is known to play a critical role in
shaping a coordinated cellular and humoral immunity and thereby enhancing the vaccine immunogenicity and
efficacy. Current vaccination strategies, however, do not include mechanisms for the temporal control of antigen
and adjuvant exposure to lymphoid tissues. Here, we propose incorporating synthetic biology approaches
to create nucleic acid-based vaccines where the kinetics of vaccine (antigen and adjuvant) exposure can
be controlled using orally-available FDA-approved small molecule drugs. This strategy is enabled using
self-replicating RNAs termed replicons that encode antigens and cytokine molecular adjuvants and encompass
regulatory mechanisms governed by the FDA-approved small molecule drug, trimethoprim (TMP). This strategy
allows the delivery of replicons encoding antigens and cytokines in vivo with a single bolus injection and then
controlling the amplitude and duration of antigen and cytokine expression by oral administration of TMP. Using
the RNA replicon platform provides several advantages: (i) it allows antigens and cytokines to be produced in
their native conformation; (ii) it self-replicates and therefore persists inside the cells longer than mRNA and
sustains a steady supply of “fresh” antigen and adjuvant; (iii) unlike DNA therapeutics, it does not harbor the risk
of genome integration and also does not require delivery to the nucleus for transgene expression. An HIV
envelope immunogen, known as the engineered outer domain (eOD-GT8), will be used as the model antigen,
and interleukine-2 and interleukine-12 will be used as the cytokine molecular adjuvants.
The Specific Aims of this project are: (1) Generate small molecule-responsive RNA replicon vaccines enabling
control over the dynamics of antigen and adjuvant expression. (2) Identify optimal temporal patterns of antigen
and adjuvant exposure maximizing the protective immunity elicited by replicon vaccines. Results from this project
will establish a vaccine platform that allows modulating and promoting the magnitude and quality of T cell and
antibody responses following immunization by taking a drug available as an oral pill, as a simple and clinically-
translatable strategy to enhance vaccine-induced immunity. In addition, elucidating the optimal cytokine and
antigen exposure patterns that confer protection will provide critical information and insights for use in conceiving
better vaccine design strategies.

Public health relevance
PROJECT NARRATIVE Despite advances made in the design of subunit vaccines, infectious diseases such as HIV, tuberculosis, malaria, seasonal flue and new emerging epidemics and pandemics remain major health problems highlighting the need for more innovative approaches in vaccine design. Current vaccine design strategies suffer from the lack of control over vaccine kinetics –the timing of antigen and adjuvant exposure– following immunization, that has shown to substantially impact the immune responses to vaccines. The proposal here describes marrying synthetic biology and immune-engineering approaches to design an RNA-based vaccine platform where the vaccine kinetics is controlled by orally-available small molecule drugs, and thereby enhancing the cellular and humoral responses elicited by vaccination.